Maintenance of the Animal Feed Regulatory Program Standards with Mutual Reliance Initiative in South Carolina

Overall Project Summary-Abstract
The South Carolina Department of Agriculture (SCDA) seeks funding support for costs associated with
maintaining a comprehensive and integrated animal feed safety program, allowing for three years of
maintenance funding with the Animal Food Regulatory Program Standards (AFRPS). Funding is also being
sought for the Mutual Reliance Track to expand comprehensive non-contract inspecƟon work conducted
under both South Carolina state and Federal FDA authority in an increased eﬀort for mutual reliance
between State and Federal partners.
The AFRPS Maintenance funds support ﬁve Feed Safety Program employees, including one AFRPS
Coordinator that is exclusively dedicated to the successful development and maintenance of the
integraƟon of AFRPS within the SCDA Feed Program. In addiƟon, parƟal AFRPS funding supports the
Feed Safety Program Manager, two Feed Safety Inspectors, and one Feed Safety Compliance Oﬃcer to
aid in programmaƟc, inspecƟonal, compliance, and enforcement eﬀorts of the Standards.
These ﬁve personnel will also aid in achieving the Mutual Reliance Track funding opportunity objecƟves
and requirements, including non-contract inspecƟon work, compliance, enforcement, reporƟng, and
workplanning eﬀorts. Their posiƟons will be parƟally supported by Mutual Reliance funds.
During the proposed three years of AFRPS Maintenance and Mutual Reliance funding, SCDA will
conƟnue to reﬁne the Feed Safety Program, including maintaining full implementaƟon of all eleven
standards and improving the collaboraƟve inspecƟonal work, ﬁrm inventory alignment, and data sharing
between State and Federal partners to ensure a cohesive mutual reliance program.

Public health relevance
Project NarraƟve The South Carolina Department of Agriculture (SCDA) has maintained full implementaƟon of all eleven of the Animal Food Regulatory Program Standards (AFRPS) as determined by its interval 3 assessment in April 2024. Through this cooperaƟve agreement, SCDA will conƟnue to use systemaƟc methods to maintain these achievements along with idenƟfying and overcoming obstacles to maintain full conformance and implementaƟon of the AFRPS. The SCDA Feed Safety Program will work to improve the mutual reliance between state and federal partners, including FDA and will conƟnue to enhance eﬀorts towards the regulaƟon of animal feed safety in South Carolina.